Mechanisms of HIV Persistence: Implications for a Cure

? DESCRIPTION (provided by the applicant): Support is requested for a Keystone Symposia meeting entitled Mechanisms of HIV Persistence: Implications for a Cure, organized by Olivier Lambotte, Steven G. Deeks and Guido Silvestri. The meeting will be held in Boston, Massachusetts from April 26 - May 1, 2015. Despite long-term control of HIV replication with combination antiretroviral therapy, HIV persists as silenced integrated DNA in memory CD4 T cells, and possibly in other cellular reservoirs, including naïve cells and macrophages. Low level replenishment of the reservoir via limited cycles of replication, may also contribute to persistence, at least in some patients. Curing HIV infection will only occur if these barriers are reversed, or if host capacity to control HIV indefinitely is improved. A number of promising interventions which might reverse latent infection have been identified, and proof that such drugs affect HIV transcription in vivo provided in pilot clinical trials. The observation that few patients treated during primary infection control durably replication-competent HIV after interrupting therapy suggests host responses might be manipulated, leading to a functional cure. The path forward will require a detailed understanding of the mechanisms of viral latency which could lead to theidentification of new drugs, and a better knowledge of the plasticity and dynamics of the main HIV cell reservoirs: CD4 T cells and macrophages. Furthermore, the role of the tissue microenvironment has to be investigated with the major help of non-human primate models. At the 2015 Keystone Symposia meeting on Mechanisms of HIV Persistence: Implications for a Cure, experts from both within and outside the HIV field will present findings from recent advances on immune mechanisms and therapeutic strategies which could lead to HIV cure. The topic of this meeting is highly relevant to the DAIDS mission to increase basic knowledge of the pathogenesis and transmission of HIV.

Public health relevance
PUBLIC HEALTH RELEVANCE: Almost 40 million people are HIV-1-infected. Combination antiretroviral therapy has had a pronounced effect on the course of HIV infection, turning the disease into a chronic one. Despite these advances, current therapeutic strategies have limitations. The Keystone Symposia meeting on Mechanisms of HIV Persistence: Implications for a Cure will provide a critical scientific forum to facilitate the dissemination and exchange of new research findings, ideas and directions, and foster increased collaboration among investigators, physician, and industry partners engaged in HIV/AIDS cure research.